Cancer Center Administration

PROJECT SUMMARY/ABSTRACT (CANCER CENTER ADMINISTRATION)
The University of Michigan (U-M) Rogel Cancer Center (Rogel) Administration provides fundamental resources
and support to the Center and Rogel senior leadership to achieve its mission to reduce the burden of cancer and
advance health equity through transdisciplinary collaboration in research, education, patient care and community
outreach. The vision of the Center is to be a leader in prevention, early diagnosis, optimal treatment and care for
all at risk of, or affected by, cancer. This is accomplished through an efficient infrastructure that facilitates timely
and value-added assistance to cancer center senior leaders and members to achieve the 2022-2027 Strategic
Plan – Discoveries to Cures to Communities. Rogel Administration adds value to the six Rogel Research
Programs, 13 (and two developing) Shared Resources (SRs), Community Outreach and Engagement, Training,
Education and Career Development, Diversity, Equity, Inclusion and Justice (DEIJ), and clinical research by
ensuring infrastructure and resources are in place to accomplish strategic priorities and goals. Rogel
Administration partners closely with leadership to foster collaborative research through inter- and intra-
programmatic meetings and retreats, 18 working groups, team science pilot projects, and multidisciplinary
committees and advisory boards. Rogel Administration provides essential support to execute all governance,
planning, evaluation, space, and resource allocation functions for the Center, including: i) Realignment of
Research Programs in response to feedback from the External Advisory Board (EAB) and in-depth evaluation of
program aims, membership and metrics; ii) Establishment of two new SRs and launch two developing SRs; iii)
Implementation and evaluation of the prior strategic plan and development a new five-year plan; iv)
Establishment of the Associate Director (AD) for Quantitative Data Science and DEIJ positions; and v)
Establishment of key leadership appointments and multi-year investments in clinical research and cancer control
and population sciences to enhance these mission critical areas. Administration oversees membership and
research administration functions for 326 members across 54 departments and nine U-M schools and colleges,
with over 100 members recruited in the last five years. Rogel Administration advances the naturally interactive
and collaborative cross-disciplinary research environment and facilitates high-impact laboratory, clinical, and
population science discoveries.